Core B: BSL3 Advanced Technologies and Animal Infection Core

Project Summary/Abstract (Core B, Stanley)
Tuberculosis (TB), caused by infection with Mycobacterium tuberculosis, remains a major cause of human
morbidity and mortality, particularly in the developing world. The spread of antibiotic resistant strains of M.
tuberculosis has increased the urgency to develop new vaccines and therapeutics to end this global pandemic.
The over-arching goal of our long-standing P01 Project has been to identify the principles of innate immune
recognition that are shared across diverse pathogens needed to develop innovative tools for treating and
preventing infections in humans. This P01 project represents a shift from tackling basic mechanisms towards
this goal by applying the collaborative insights of our group to tackle the uniquely challenging problem of
vaccine development for TB. TB research is inherently difficult as it requires dedicated facilities and
infrastructure, with stringent biosafety, training, and oversight requirements in order to work safely with this
biosafety level 3 pathogen. Furthermore, success of the P01 requires integrated and collaborative mouse-
based infection and vaccination studies which will require a high degree of standardization and oversight in
training, procedures and core reagents. This Core will function to overcome these barriers by providing
comprehensive, state-of-the-art research support to all four laboratories of this Program for the manipulation
and study of M. tuberculosis in a reliable, integrated, and cost-efficient manner.

Public health relevance
Project Narrative (Core B, Stanley) The objective of the BSL3 Core is to provide comprehensive, state-of-the-art research support to all four projects of this P01 in the manipulation and study of M. tuberculosis, a notoriously difficult pathogen to study. This Core serves to lower the substantial barriers inherent in working with this pathogen, to provide access to state-of-the-art technologies, and to ensure standardization across projects.